Mechanisms in Innovation in Vascular Disease

DESCRIPTION (provided by applicant): This program will train 6 postdoctoral fellows annually in mechanisms and Innovation in vascular disease. The program goals include rigorous training in the scientific method, critical analysis, logical reasoning and independent thinking, all within a highly collaborative working group. Trainees will develop a focused area of translational vascular research expertise and will be exposed to a wide range of complementary research techniques. Mentors will provide collegial and productive collaboration, and help to hone skills in oral and written communication, and to instill respect for the responsible conduct of research. Fellows will undergo a minimum two-year education and research program, although we only intend to fund the first year through the institutional T32. Fellows will be encouraged and mentored in their development of funding proposals for the second year. The overarching goal for this program is to produce researchers who are well-schooled in the fundamental problems of vascular disease, and are driven to find innovative strategies to tackle those problems, thereby translating basic research into clinical success. Fellows will receive their training in a multidisciplinary milieu of fundamental, translational and clinical research in vascular biology and disease. The Stanford Cardiovascular Institute (CVI) offers a unique platform by which to train the next generation of basic and translational scientists. Mentors for the proposed program, all members of the CVI, come not only from vascular medicine, but also from materials science, bioengineering, imaging, and health research and policy. Brought together in a collaborative Institute, these scientists share a common interest in the mechanisms behind vascular development and disease.